EYA in Retinal Angiogenesis

Abstract Angiogenesis is essential for normal retinal development, however pathological retinal angiogenesis can lead to blindness. This occurs in conditions such as retinopathy of prematurity (ROP), age-related macular degeneration, and diabetic retinopathy. An essential step in angiogenesis is the migration, proliferation and differentiation of endothelial cells into newly formed capillary networks. We have preliminary data showing that the EYES ABSENT (EYA) proteins (which are activators of transcription as well as tyrosine phosphatases) promote angiogenesis, and that genetic ablation of Eya3 leads to defects in the retinal vasculature. We hypothesize that the tyrosine phosphatase activity of the EYA proteins is pro-angiogenic and that inhibition of this catalytic activity represents a novel molecular target for the treatment of retinal vasculopathies.To test this hypothesis we propose two aims: (I) To investigate the function of EYA during normal retinal angiogenesis using vascular endothelial specific targeted deletion of Eya3 and Eya1, and (II) To validate EYA as a molecular target for anti-retinopathy drug development by testing specific inhibitors of the EYA tyrosine phosphatase in the oxygen-induced mouse model of retinopathy. These aims will be accomplished using a combination of techniques including cell- culture based assays, chemical biology, mouse genetics, and animal models of retinopathy. RELEVANCE. At the completion of this project we will have a comprehensive understanding of the role the EYA proteins play in both developmental and pathological angiogenesis. The formation of abnormal ocular vasculature is a major cause of catastrophic vision loss both in premature infants and in adults with diseases such as diabetes and age-related macular degeneration. Hence deciphering the molecular mechanisms underlying abnormal angiogenesis is important. Such conditions are traditionally treated with laser-mediated ablation of the retina, and more recently with intraocular administration of anti-VEGF antibodies; however, neither of these treatment options is without limitations. The EYAs represent a novel and druggable target for treating proliferative retinopathies, and an essential feature of this project is the validation of EYA as a target for anti-angiogenic drug development.

Public health relevance
Narrative The abnormal growth of blood vessels in the retina is an essential feature of many common vision-threatening conditions including retinopathy of prematurity, diabetic retinopathy and the wet type of age-related macular degeneration. Current therapy includes laser-ablation of non-vascularized regions of the retina or treatment with agents that attenutate vascular endothelial growth factor. Neither of these options is optimum in terms of side-effects, invasiveness and cost. There thus remains an unmet need to develop new treatments for retinopathies. We have found that the catalytic activity of the protein Eyes Absent (EYA) promotes angiogenesis and that small molecule inhibitors of the Eyes Absents attenuate angiogenesis. In this project we propose to determine the cellular and molecular mechanisms by which the Eyes Absents play their role in retinal vascular development, and how they might be activated in disease states. In addition we will use existing Eyes Absent inhibitors in an animal model of retinopathy to validate the proposal that the EYAs represent a novel target for future drug development.